Novel therapeutics to treat TB by stimulating bacterial cAMP production

PROJECT SUMMARY / ABSTRACT
In this project we are focused on chemically perturbing Mtb persistence mechanisms as a way to augment
or shorten TB treatment. It is understood that Mtb metabolizes host lipids to persist and recent work has
discovered that chemically stimulating cAMP production in Mtb blocks the bacterium’s ability to metabolize host
lipids. Importantly, two clinical candidates with this mechanism of action (Rv1625/cya agonists) improve the
bactericidal and sterilizing activity of BPaL and shorten treatment in mice. The overall objective of this project is
to examine how cAMP stimulating compounds exert their inhibitory properties on Mtb and explore how these
compounds could be leveraged to mitigate resistance while synergizing with other TB drugs. The central
hypothesis of this work is that cAMP stimulators inhibit Mtb growth by perturbing bacterial lipid metabolism and
combining multiple cAMP stimulators with unique targets will amplify this inhibitory process and reduce the
frequency of resistance to this class of compounds.
Activating cAMP synthesis in Mtb blocks lipid metabolism but a mechanistic understanding of this process
is lacking. Thus, we will focus on characterizing a novel cAMP stimulator (CU35), determine how cAMP blocks
lipid metabolism in Mtb, and we will combine multiple chemical and genetic approaches to amplify cAMP
production in Mtb to determine how this impacts Mtb physiology (Aim 1). We have found that CU35 stimulates
cAMP production independent of Rv1625/cya suggesting that other compounds that stimulate cAMP synthesis
in Mtb may exist. To discover additional cAMP stimulators, we will conduct a novel high-throughput chemical
screen to identify compounds that stimulate cAMP in a Rv1625/cya-independent manner. Compounds emerging
from our screen will be prioritized based on structure novelty, safety, potency, PK properties, and synergy with
known cAMP stimulators (Aim 2). The most important therapeutic property of cAMP stimulators is their ability to
improve the bactericidal and sterilizing activity of BPaL in mice. Thus, we will evaluate our innovative idea that
stimulating cAMP through multiple independent routes could amplify synergy with BPaL in mice. We will also
evaluate lead compounds from our chemical screen for BPaL potentiating activity in mice (Aim 3). Overall, these
studies are highly significant because they will provide information and new lead compounds to ultimately allow
us to combine multiple cAMP stimulators with BPaL and achieve an innovative short acting TB drug regimen.
The studies will provide a basic biological understanding cAMP signaling in Mtb, define the novel mechanism of
action involving cAMP-dependent control of lipid metabolism in Mtb, and will address practical drug development
questions around synergy with cAMP stimulators.

Public health relevance
Project Narrative Mycobacterium tuberculosis is the causative agent of Tuberculosis (TB) and is responsible for approximately 1.5 million deaths annually. Anti-TB chemotherapy is slow and prolonged due to M.tuberculosis’s ability to persist for long periods of time in human hosts by metabolizing lipids. This proposed research will: (i) characterize how novel cAMP stimulating compounds block lipid metabolism in M. tuberculosis, (ii) identify new cAMP stimulator compounds and their molecular targets, and (iii) evaluate the therapeutic potential of combining multiple different cAMP stimulators to synergistically kill M. tuberculosis in animal models. The overall goal of this work is to identify promising therapeutic agents that target M. tuberculosis persistence as a way to shorten anti-TB chemotherapy.